Cancer Research Career Enhancement and Related Activities

CANCER RESEARCH CAREER ENHANCEMENT AND RELATED ACTIVITIES: PROJECT SUMMARY
Siteman Cancer Center (SCC) has a strong research training environment and a long-standing record of trainee
success. Rooted in the robust educational infrastructure of Washington University, SCC enhances training and
education initiatives available to cancer researchers and efforts to develop a more diverse cancer research
workforce. The SCC Cancer Research Career Enhancement (CRCE) will build upon these current efforts to:
1. Provide new cancer education opportunities at SCC that fill specific existing training gaps by funding
new specific cancer research programs, supplementing existing programs to enable more SCC member
participants, supporting travel to select scientific meetings, and sponsoring seminars and workshops.
2. Coordinate existing research education and training activities at Washington University by sharing and
promoting didactic courses and other training opportunities across the spectrum from undergraduate to junior
faculty. We also share lessons learned from the Cancer Biology Training Consortium (CaBTraC) meetings
and the eight F, eight K, four T32, two K99/R00, and one K12 Calabresi award from the NCI to help identify
additional training grant opportunities and slots for eligible candidates.
3. Ensure effective training opportunities for underrepresented minorities (URMs) by funding the
Community Research Fellows Training program, requiring inclusion and diversity training for faculty and staff,
expanding URM recruitment for cancer research training, and enhancing URM retention efforts.
4. Develop new initiatives to enhance education and training opportunities by expanding existing SCC
CRCE opportunities to better support the cancer research workforce and improve programming through
structured evaluation and filling of existing training gaps. New efforts will include establishment of a Cancer
Biology PhD program, additional grant writing support, hosting team science symposia, as well as expansion
of cancer biology courses, workshops, and clinical research programs across other training programs. We
will also develop workshops and provide mentoring for continued development of faculty, as well as for
community scientists and physicians in emerging areas of cancer research.
We believe the current and future SCC CRCE programming will transform the future cancer research workforce.
The CRCE will do this by providing the training, education, and mentorship needed to successfully advance
trainees to independence. We will build upon successful existing programs and streamline efforts to train cancer
researchers throughout all specialties of the SCC. We will target some of the key needs of trainees, developing
focused mentorship, supportive research communities, tailored career guidance, and practical understanding of
available funding sources and grant submissions. With this foundation of support in place, we believe our
investigators will transition to independence more quickly, have the ability to focus on their patients and research,
and will result in making significant contributions to cancer research and patient outcomes.